San Diego Nathan Shock Center

PROJECT SUMMARY – Research Development Core
The SD-NSC Research Development Core (ResDev Core) will provide support for career development of
junior researchers entering the field of basic aging biology, as well as established investigators who wish to join
the field of aging research. Specifically, the ResDev Core will support the scientific goals of SD-NSC to
enhance the understanding of the role of cell heterogeneity in the aging process by promoting career
development of aging researchers in three different ways: 1) by providing seed funding for projects interested
in taking advantage of the unique scientific services offered by the SD-NSC Research Resource Cores
(Human Cell Models of Aging Core, Heterogeneity of Aging Core, and Integrative Models of Aging Core), 2) by
providing conceptual and practical training in the scientific services covered by the three Research Resource
Cores, and 3) by establishing a personalized mentoring program between junior and senior members of the
NSC network and beyond. The ResDev Core will be led by Dr. Malene Hansen, Sanford Burnham Prebys
Medical Discovery Institute (SBP), who brings local, national, and international aging research knowledge, and
extensive expertise and high motivation in mentoring junior scientists. The approach will capitalize on a highly
integrative and innovative approach by providing conceptual and practical training in the scientific Cores along
with formalized mentoring in grant writing and career development. First, a two-track pilot grant program will be
launched in which applicants apply for funding for Core usage and mentoring, either directly from submitted
applications or via a grant-writing support program. Second, a one-day workshop to provide training in the
scientific Cores will take place the day after the yearly La Jolla Aging Meeting, a free one-day aging
symposium at the Salk Institute for Biological Studies (Salk) in San Diego organized by researchers at Salk
and SBP. This workshop will feature modules on the techniques and analyses provided by the three scientific
cores, along with information about potential career tracks in scientific Core services. In addition, a module on
grant writing will be offered. Third and finally, a two-track personalized mentoring program will be established in
which junior researchers will be mentored by established investigators, either as part of the pilot grant program
or via pairing of mentee-mentor relationships formed at national NSC meetings, and beyond.